Regulation of microglial lipid metabolism and immune functions by SHP-1 in Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease (AD) is a debilitating neurodegenerative disease affecting millions of people in the United
States; however, there is still an immense need for improved therapeutic strategies to treat or slow its
progression. Increasing evidence from human AD genetic studies and experimental animal models has
implicated microglia, the brain-resident macrophages, and their associated immune functions in AD
pathogenesis. In particular, recent studies have linked microglial immunoreceptor tyrosine-based activating
(ITAM) and inhibitory motif (ITIM) receptors, including TREM2, CD33, CD22, and SIGLEC-11, to AD risk. While
spleen tyrosine kinase (SYK) is known to drive protective microglial immune functions downstream of ITAM
receptors, less is known regarding the intracellular signaling molecules that orchestrate ITIM receptor-mediated
coordination of microglial immune functions in AD. In the peripheral immune system, the SH2-domain-containing
phosphatase (SHP)-1 (encoded by the gene Ptpn6) is known to execute immune inhibition downstream of
multiple ITIM receptors and shut down the ITAM-SYK signaling axis. Despite this, the role of SHP-1 in regulating
microglial biology, immune functions, and AD pathogenesis is largely unknown. To bridge this gap in knowledge
and investigate how SHP-1 shapes microglial biology in response to amyloid beta (Aβ) pathology, my lab
generated SHP-1fl/flCx3cr1Ert2Cre mice that harbor a conditional deletion of SHP-1 in brain macrophages and
further crossed them with 5xFAD mice, a widely used model of amyloidosis (further referred to as 5xFAD SHP-
1MG mice). In my preliminary studies, I found that brain macrophage deletion of SHP-1 in 5xFAD SHP-1MG mice
leads to a marked reduction Aβ plaque load, enhances microglia-plaque interactions and microglial Aβ
phagocytosis, and significantly reduces microglial lipid droplet burden when compared to Cre-negative 5xFAD
littermate controls. Additionally, I conducted a transcriptional analysis of isolated SHP-1-deficient brain
macrophages and discovered that SHP-1 functions downstream of ITIM-containing receptors to regulate
microglial activation and lipid metabolism. Given these preliminary findings as well as the emerging evidence
linking lipid droplet accumulation to microglial dysfunction and AD pathogenesis, I hypothesize that SHP-1 is a
central regulator of microglial lipid metabolism that functions downstream of ITIM receptors to influence
Alzheimer’s-associated disease pathogenesis. In Aim 1, I will uncover which microglial ITIM-containing
receptors employ SHP-1 to inhibit microglial immune functions in Aβ amyloidosis. In Aim 2, I will determine how
SHP-1 orchestrates microglial lipid metabolism. Overall, the completion of the proposed studies will pioneer new
insights into the role of SHP-1 in orchestrating microglial immune functions and lipid metabolism in AD-related
pathogenesis. Further, this work will uncover novel microglia-specific players (i.e., SHP-1) that can be targeted
to treat AD and easily translated to other neurological diseases in which microglia play critical roles.

Public health relevance
PROJECT NARRATIVE Microglia, the brain-resident immune cells, defend the brain against pathogenic amyloid beta (Aβ) in Alzheimer’s disease (AD), a debilitating neurodegenerative disease impacting millions of people with few disease-modifying treatments. While human genome-wide association studies and experimental mouse models of AD pathology have strongly implicated microglial surface receptors in AD risk, the intracellular signaling molecules that orchestrate microglial immune functions in AD are poorly understood. In my preliminary studies using an Aβ- driven mouse model of AD, I identified that microglia-specific deletion of the intracellular phosphatase SHP-1 leads to a striking reduction in Aβ load, increased microglia-plaque interactions, enhanced Aβ phagocytosis, and reduced lipid droplet burden; therefore, this proposal will determine the molecular mechanism by which SHP-1 regulates microglial immune functions by (1) identifying the microglial receptors employing SHP-1 to dampen neuroprotective microglial immune functions (Aim 1) and (2) determining how SHP-1 regulation of microglial lipid metabolism governs Aβ phagocytosis (Aim 2).